Therapeutic modulation of the phagocytosis axis as a novel glioblastoma immunotherapy

ABSTRACT:
Glioblastoma (GBM) is the most common and aggressive primary malignant brain tumor in adults. Currently,
there is no effective therapy available, and the disease is universally fatal with a median overall survival of less
than 15 months among patients who received standard treatments. Cancer immunotherapy holds great
promises for GBM treatment, and growing evidence suggests that boosting the body's immune system can
help eliminate highly aggressive and advanced tumors, including those resistant to conventional therapies.
However, despite recent successes of cancer immunotherapies in other solid tumors, its effectiveness against
GBM remains unclear. Furthermore, even for highly immunogenic tumors, only a small percentage of patients
are likely responders. Therefore, there is an urgent need for the development of immunotherapies that are
consistently effective for GBM patients. We have recently identified that the standard-of-care chemotherapeutic
agent for GBM, temozolomide (TMZ), can induce immunogenic changes within the tumor via a mechanism that
is distinctive and novel from their well-characterized DNA damaging effects. GBM cells exposed to TMZ
experience a significant elevation in endoplasmic reticulum (ER) stress response with the corresponding
translocation of ER chaperone protein, calreticulin (CRT) to the plasma membrane. CRT is a pro-phagocytic
molecule that signals the recruitment for professional antigen presenting cells (APCs) for phagocytic clearance.
However, TMZ-induced CRT translocation alone is insufficient to promote significant tumor clearance by APCs,
suggesting that additional evasive signals are used by GBM to avoid eradication by the innate immune system.
We subsequently showed that the anti-phagocytotic CD47 is overexpressed in GBM. Although the blockade
of CD47 has been investigated as a potential therapy for multiple human cancers, its anti-tumor effect has
been inconsistent. Therefore, based on these observations, we hypothesize that the simultaneous induction of
CRT by TMZ and the blockade of CD47 signaling are both required to produce consistent and potent anti-GBM
responses. Enhanced GBM phagocytosis and tumor-associated antigen cross-presentation by APCs
subsequently heighten anti-tumor T cell adaptive response. Our proposal will mechanistically determine how
TMZ with CD47 blockade primes the antigen-specific anti-GBM T cell responses, and evaluate the therapeutic
utility of the combined treatment against TMZ-sensitive and TMZ-resistant GBMs. The proposed study will
validate the clinical utility of the combined therapy in patient-derived GBM xenograft models implanted in mice
with reconstituted human immune system. If successful, our study will demonstrate that conventional cytotoxic
agents may possess immunogenic properties that can be harnessed to enhance GBM immunotherapy and
generate relevant preclinical rationale to support further clinical investigations of TMZ and anti-CD47
combination for the treatment of GBM, particularly these resistant to TMZ.

Public health relevance
NARRATIVE Glioblastoma (GBM) is the most common and malignant primary brain tumors in adults, and is universally fatal with current treatment options ineffective and debilitating. We have discovered that the standard-of-care chemotherapeutic agent temozolomide (TMZ) possess an alternative mechanism of action that can make GBM cells more visible to the body's innate immune system, and when combined with the blockade of the immune suppressive molecule CD47 that is commonly expressed in GBM cells, we achieved significant tumor inhibitory effects and prolong survival in mice. This proposal therefore focuses on the mechanistic examination of the anti-tumor immune responses generated by the novel combinational therapy and systemically evaluate its role in treating GBM.